Sensitization of developing sensory neurons after incision

ABSTRACT: Approximately 15-20% of children experience persistent or chronic pain. However, compared to
adults, we know relatively little about the mechanisms of pediatric pain development. A basic understanding of
nociceptive processing in the immature nervous system is therefore crucial in order to develop more
appropriate treatments for pain in children. The developing peripheral nervous and immune systems are
functionally distinct from adults. These systems are vulnerable to effects of early life injury which can influence
outcomes related to nociception following subsequent injury later in life (i.e. “neonatal nociceptive priming”).
We have found that macrophages are a key player in both early life nociception and neonatal nociceptive
priming responses after incision injuries. Macrophages were found to retain an epigeneetically driven memory
of early life injury that leads to a more pro-inflammatory state such that re-injury causes a prolonged behavioral
and physiological responses in the peripheral nervous system. Observed changes in the PNS that underlie
neonatal nociceptive priming are blocked by genetic targeting of the nerve growth factor (NGF) receptor, p75,
in macrophages, one of the key factors found to be part of the epigenetic memory. New pilot data suggests
that mast cells (MCs) may be the source of NGF that sustains the pro-inflammatory state created by the
epigenetic memory in macrophages. In addition, sensory neurons also appear to generate an epigenetically
driven memory that contributes to the pro-inflammatory environment in the muscles after injury leading to
prolonged hypersensitivity. The main goal of this proposal is to determine how the epigenetic modifications in
this novel neuro-immune circuit regulates neonatal nociceptive priming. Specific Aim 1 will use our novel ex
vivo somatosensory recording preparations and pain-like behavioral assays along with cell specific transgenic
approaches to determine the additional epigenetically modified factors in macrophages (e.g. parvalbumin) that
regulate neonatal nociceptive priming. Specific Aim 2 will test whether knockdown of neuronally produced
cytokines (e.g. interleukin 34) modulates neonatal nociceptive priming using similar approaches with nerve
targeted gene knockdown strategies. Finally, Specific Aim 3 will use behavioral analyses and/or ex vivo
recording to determine the influence of MCs and MC produced NGF in neonatally incised mice on the
prolonged effects to subsequent adolescent incision. These aims will be complemented by calcium imaging
analysis of human iPSC derived sensory neurons treated with media from macrophages or MCs to enhance
translational potetinal of these studies. These experiments will allow a better understanding of the unique
mechanisms by which neuroimmune signaling contributes to neonatal nociceptive priming. These studies will
facilitate understanding of the transition from acute to chronic pediatric post-surgical pain, and will allow us to
determine the utility of targeting immune cell or sensory neuron memories as a pain therapy for children.

Public health relevance
NARRATIVE The results of the proposed research will significantly enhance understanding of the molecular mechanisms underlying sensory neuron responses after peripheral injury in neonates and provide novel information for use in the development of new avenues of research and therapies for post-surgical pain in children. The information obtained from these innovative studies will allow us to better understand the functional implications of how cellular memories regulate sensory neuron function and the role they play in the advancement of pediatric pain states.